CAMPBELL Administrative Core: Muscular Dystrophy Cooperative Research Center

PROJECT SUMMARY The Administrative Core of the Senator Paul D. Wellstone Muscular Dystrophy Cooperative Research Center will coordinate the activities within and outside the Center, as well as promote an interactive and collaborative research environment. The administrative responsibilities of Core A include the following: organization of the flow of project information; distribution of research effort; allocation of budgetary and other resources; preparation of annual budgets and projections; scheduling and facilitation of monthly Neuromuscular Disease Conference meetings; promotion and coordination of community outreach projects (including the annual Patient and Family Conference); and consultation with the Dean regarding progress, scientific direction, administrative issues and concerns, and future plans. The scientific responsibilities of Core A include the following: integration, coordination, and direction of research projects as needed; consultation with advisors and consultants concerning the importance and progress of Center research relative to other developments in the area of muscular dystrophy; identification of seminar speakers and coordination of their participation and contributions to the Center; and hosting of an annual family conference for patients and their families. This core will also facilitate expansion of our collaboration with national and international leaders in the field of congenital/limb-girdle muscular dystrophy, particularly researchers and clinicians at other Wellstone Centers throughout the United States. The Core A Administrator will coordinate an annual open house for the Muscular Dystrophy Association branch in Cedar Rapids, Iowa, at which seminars are held for approximately 100 patients/families; these describe current and planned research, as well as advancements in understanding and treating muscular dystrophy. The Administrator is also responsible for coordinating the Wellstone Steering Committee Face-to-Face Meeting when this is hosted by the University of Iowa, coordinating both the patient and family tours and the meetings among Core Directors and Project Leaders that take place during this event.